THWART-TB : Testing Health Workers At Risk to advance our understanding of TB infection

PROJECT SUMMARY
Tuberculosis (TB) remains a leading infectious cause of death globally. 1.7 billion people
worldwide are estimated to have been infected with TB (LTBI); yet TB infection remains poorly
understood. Current LTBI tests cannot distinguish between current infection versus a persistent
immune response to a cleared infection and have a low predictive value to identify which people
are at risk of developing incident active TB disease. We propose to establish a prospective
longitudinal cohort study of health workers (HWs) in Cape Town, South Africa, where our
preliminary data reveals HWs have a high annual TB infection risk (34%). This cohort, who will
undergo frequent serial evaluation (every 3 months) with a combination of novel assays never
previously evaluated together, presents a unique opportunity to evaluate immune responses at
the time of initial infection and to characterize the dynamic profile of these immune responses
over time in a high-risk population. This interdisciplinary study addresses three knowledge gaps:
1) We will evaluate serial interferon gamma release assay (IGRA) responses to identify early TB
infection and characterize the dynamics of IGRA conversion and reversion, which will contribute
to understanding of transient versus persistent infection. Furthermore we will elicit HW
preferences regarding serial LTBI testing strategies and decision making that will inform the
implementation of HW TB screening, which is urgently needed given their occupational TB risk.
2) We will evaluate the temporal dynamics of immune responses to TB by measuring serial
RNA biosignatures, C-reactive protein, and Mycobacterium tuberculosis (Mtb)-antibody
responses. We will determine whether biosignature results are persistently elevated or wane
over time and how these correlate with other measures of immune response. We will be able to
comprehensively profile changes in Mtb-antibody responses by not only quantifying IgG levels
but by evaluating all isotypes, subclasses and Fc-receptor binding profiles.
3) We will evaluate serial blood samples for detectable Mtb, based on testing of CD34-positive
PBMCs and a phage-based assay (Actiphage). Comparing novel Mtb DNA detection approaches
could enhance understanding and risk stratification for incident TB in high-risk populations.
Our novel data on Mtb immune responses and Mtb quantification in people with LTBI will improve
understanding of the correlates of TB immune clearance versus persistence and could help to
identify individuals at a higher risk of progression. This study is aligned with the NIAID mission to
‘advance the understanding and diagnosis of re-emerging diseases such as TB’ and to ‘develop
international research capacity to respond appropriately to re-emerging disease threats’.

Public health relevance
PROJECT NARRATIVE It has been estimated that 1.7 billion people have tuberculosis (TB) infection; yet current tests are unable to predict which people are at highest risk of developing TB disease, which can be life-threatening. This project will use a range of novel tests to characterize the profile of immune responses to TB over time in a high-risk population of South African health workers. The knowledge generated will improve our understanding of TB infection and help to identify which people exposed to TB may remain at risk, enabling us to better target preventive strategies.